Alternative splicing regulation of CLTC in the heart

ABSTRACT
Alternative splicing wields extraordinary power in controlling protein function, cell development, and
tissue identity. Alternative splicing is a co- and post-transcriptional RNA processing mechanism that enables
a single gene to generate more than one transcript, thereby expanding the diversity of a cell’s proteome.
This ubiquitous mechanism of gene regulation occurs in more than 95% of multiexonic genes in humans.
The heart exhibits one of the most tissue specific and highly conserved alternative splicing programs, and
the reprogramming of these splicing patterns is a hallmark of cardiovascular diseases.
In the heart, genes encoding membrane trafficking proteins are alternatively spliced in a tissue-specific
manner; however, how these events are regulated and the functional roles of these isoforms within
cardiomyocytes remains elusive. This proposal will investigate one specific membrane trafficking splicing
event that takes place in the gene encoding the clathrin heavy chain (CLTC) protein. CLTC classically
functions during clathrin-mediated endocytosis but plays unconventional structural roles as well. Cltc exon
31 alternative splicing occurs in the heart, and we have previously observed that deletion of Cltc exon 31
using CRISPR editing in mice impedes the progression of hypertrophy and heart failure after pressure
overload. I hypothesize that the regulation of Cltc exon 31 splicing in the heart modulates the endocytic and
structural functions of clathrin, which impacts cardiomyocyte cell growth. I will address this hypothesis with
two aims. In Aim 1, I will determine the physiological consequences of Cltc splicing in the heart by assessing
the impact of CLTC isoform expression on cardiomyocyte cell signaling, cytoskeleton architecture, and
protein-protein interactions (immunoblotting, confocal microscopy, and proteomics). In Aim 2, I will identify
the regulatory mechanism governing Cltc exon 31 splicing in the heart. I will demonstrate that the quaking
(QKI) and polypyrimidine tract binding protein 1 (PTBP1) RNA-binding proteins control Cltc exon 31 splicing
and that these RBPs bind with high affinity to consensus motifs located within the Cltc pre-mRNA transcript
(protein knockdowns, in vitro reconstitutions, and minigene reporter expression paired with motif deletions).
My long-term goal is to have a research-intensive career and become an independent leader in
cardiovascular biology. The training that I will receive during this fellowship period will facilitate my scientific,
professional, and personal growth by providing opportunities to expand my experimental toolkit, network
with esteemed researchers, and increase my confidence as a strong scientist. Importantly, the University of
North Carolina at Chapel Hill offers a rich research community of RNA, cardiovascular, genetic, and
molecular cell biologists, and I have recruited mentors and collaborators with expertise in each of these
fields. All of them are committed to educating and supporting me throughout my fellowship, which will set
me up for success with both my research proposal and my future scientific career.

Public health relevance
PROJECT NARRATIVE A hallmark of cardiac diseases is mis-regulated RNA processing. This project seeks to understand how RNA processing of CLTC, a molecule that controls protein trafficking and cell structure, contributes to the function of the heart. The insights gained from this research will be fundamental to our knowledge of cardiac physiology and lay the foundation for identifying future therapeutic targets of cardiac diseases.